Training Program in Basic Neuroscience

Project Summary/Abstract
This is a renewal application for a Jointly Sponsored Ruth L. Kirschstein National Research Service
Award Institutional Predoctoral Training Program in the Neurosciences from the University of
California, Davis. The goal of the program is to provide entering students with a broad education in
the fundamental principles of neuroscience, which will form the foundation for their specialized
research in subsequent years. The program operates under the auspices of the interdisciplinary
Neuroscience Graduate Program at UC Davis, which offers training in all areas of neuroscience and
is guided by a large group of outstanding basic scientist and clinical researcher faculty.
The support of 6 predoctoral trainees to be selected annually is requested. Trainees will receive one
year of support from the Training Program, typically in their first year. Internal support mechanisms
and other extramural grants, including individual fellowship awards will be used as support for the
remaining years of graduate training. The Training Program exposes trainees to as broad a range of
modern neuroscience subdisciplines and technologies as possible, including cellular and molecular
neuroscience, neuroanatomy and neurophysiology, neurogenetics, systems neuroscience, cognitive
neuroscience, computational neuroscience and the neurobiology of psychiatric and neurological
disease.
Trainees will receive a rigorous basic training through formal course work, seminars and journal clubs
and laboratory rotations and will participate in colloquia in which they will be expected to regularly
make oral presentations. Students will also be immersed in a culture that values diversity and
promotes community outreach. Thus, students will be well prepared for their dissertation research
and for future, independent careers in basic and disease-related neuroscience research.

Public health relevance
Project Narrative The goal of this training program is to provide broad training in the fundamental principles of neuroscience to six first-year predoctoral students through formal course work, seminars and laboratory rotations. These students will be well-prepared for their dissertation research and for future, independent careers in basic and disease-related neuroscience research.